Effect of vibration on muscle properties, physical activity and balance in children with cerebral palsy

PROJECT SUMMARY/ABSTRACT
Cerebral palsy (CP) is a neuromuscular disorder that affects approximately 800,000 individuals in the U.S. Low
muscle volume, strength and quality, poor balance and limited participation in physical activity are significant
concerns in children with CP because they are strongly linked to their high risk of chronic disease. Therefore,
identifying effective treatment strategies that address these issues is imperative. One treatment that has re-
ceived significant attention is high-frequency, low-magnitude vibration (HLV). However, studies examining the
effect of HLV on muscle development, balance and physical activity in children with CP are lacking. Our long-
term goal is to identify treatments that reduce the risk of chronic disease in children with CP. The overall objective
of this application is to determine the effect of a daily HLV treatment on muscle volume, strength, and quality, as
well as physical activity and balance in ambulatory children with CP. Our central hypothesis is that a daily HLV
treatment will increase leg muscle volume and strength, reduce leg intramuscular fat, increase physical activity
and improve balance in children with CP. To test the central hypothesis, we will pursue the following aims: 1) to
determine the effect of a daily HLV treatment on muscle volume and muscle strength in ambulatory children with
CP; 2) to determine the effect of a daily HLV treatment on muscle quality in ambulatory children with CP; 3) to
determine the effect of a daily HLV treatment on physical activity in ambulatory children with CP; and 4) to
determine the effect of a daily HLV treatment on balance in ambulatory children with CP. A randomized con-
trolled trial with one treatment arm will be used to accomplish the aims. Muscle volume and intramuscular fat in
the leg will be assessed using magnetic resonance imaging. Muscle strength of the leg plantar flexors will be
assessed using a dynamometer. Physical activity will be assessed using activity monitors. Balance will be
assessed using measures of standing postural sway, as well as tests of fall recovery. HLV will be administered
10 min/d for 6 months. The proposed study is significant because children with CP have small, weak and fat-
infiltrated muscles, poor balance and low physical activity which places them at a high risk for developing chronic
disease. We propose an innovative intervention utilizing HLV and a comprehensive assessment of muscle prop-
erties, balance and physical activity in children with CP. We expect to determine that HLV increases muscle
size, strength and quality, physical activity and balance in children with CP. The results of the study will have a
positive impact as they will serve as a key step toward establishing the effectiveness of HLV as treatment to
combat the high risk of chronic disease in children with CP.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because cerebral palsy is the most common developmental disability in children and low accretion, strength and quality of the their muscles, poor balance and low participation in physical activity are major issues. Therefore, identifying effective treatment strategies that lead to better muscle development and balance and increased physical activity participation is needed. If a mild vibration treatment is found to increase muscle volume and strength and decrease fat infiltration of the muscles, while increasing balance and physical activity participation, it would present a viable strategy for reducing chronic disease risk in children with cerebral palsy.